Tumor-derived extracellular vesicles in the pre-metastatic niche.

Metastasis is the leading cause of death in cancer patients, and its early detection and prevention are currently
difficult. Thus, a better understanding of the earliest stages of metastasis, is an important and presently unmet
challenge. The objective of this application is to gain a better understanding of the mechanisms leading to the
formation of the pre-metastatic niche (PMN), an early step in the metastatic process, with the goal of finding
targets for intervention. The focus of this highly collaborative grant is on the role of tumor-derived extracellular
vesicles (TEV) in melanoma (MEL) and neuroblastoma (NB). Recently published1 and preliminary data revealed
that TEV are primarily, but not exclusively, captured by macrophages (MF) in metastasis-tropic organs prior to
their colonization by tumor cells, and that they trigger an inflammatory reaction in MF that includes the production
of interleukin (IL)-18 and IL-1β and activation of the inflammasome. We also found that TEV-capturing cells in
the PMN are heterogenous, including MF and non-MF cells, with the contribution of non-MF cells, including
myeloid derived suppressive cells (MDSC), increasing as the PMN evolves toward a metastatic niche (MN).
Using newly murine models of orthotopic metastasis to track endogenously released TEV and their capture in
the PMN developed in our laboratory, state of the art single cell analysis methods, and a unique collection of
patient samples, we will test the hypothesis that TEV capture by resident MF in the PMN triggers via the
inflammasome the release of inflammatory cytokines/chemokines, which signal for the recruitment of
bone marrow -derived myeloid cells (BMDMC) and MDSC to the PMN, supporting the subsequent
colonization of the PMN by metastatic tumor cells. In AIM 1, we will perform spatiotemporal analysis of the
PMN formation and its evolution into MN, identifying at the single cell level subpopulations of TEV-capturing cells
defined by their RNA and protein expression. We will use pharmacological and loss-of-function approaches
targeting the activation of the inflammasome in the PMN to determine whether the development of the PMN is
disrupted and metastatic colonization inhibited. In AIM 2, we will perform kinetics analysis of the colonization of
the PMN by BMDMC. We will determine whether TEV-capturing MF send signal(s) that promote the
differentiation of BMDMC into MDSC through the release of IL-1β and IL-18 or other cytokines. We will
demonstrate the role of IL-18 and IL-1β on PMN formation and metastatic colonization using pharmacological
inhibition of IL-18 or mice deficient in IL-1β or IL-18. In AIM 3, we will use a unique collection of retrospective
and prospective liver tissues from children with NB to characterize by Imaging Mass Cytometry the PMN in
human samples, comparing the results with those from murine models. We expect to identify mechanisms
involved in the formation of the PMN and MN, providing a strong premise for development of intervention
approaches that could prevent the initiation of metastasis. Considering the current absence of therapeutic agents
preventing metastasis, the project, if successful, could have a significant impact for MEL, NB, and other cancers.

Public health relevance
NARRATIVE Most patients with cancer succumb to their disease because cancer cells can disseminate to various organs, a complex process called metastasis, which is hard to detect early on, to prevent and to treat. This grant proposal focuses on developing a mechanistic understanding of one of the earliest steps in metastasis, the formation of the pre-metastatic niche, and on testing the hypothesis that small vesicles released by tumor cells and taken by sentinel immune cells in organs prone to metastasis trigger an inflammatory reaction that favors organ colonization by metastatic tumor cells. The long-term goal is to identify targets within the metastatic process to intervene when it is in early development.